Identifying and targeting the genetic determinants of immune suppression and immunotherapy failure in prostate cancer.

PROJECT SUMMARY
The goal of this project is to determine the mechanisms by which interferon gamma (IFNg) signaling promotes
tumor growth and immune suppression to drive neuroendocrine prostate cancer (NEPC) progression and
resistance to immune checkpoint blockade (ICB) therapies. Following hormone therapy failure, some patients
develop an aggressive subtype of prostate cancer known as NEPC that is lacking in effective treatment options.
Though most prostate cancers are defined by a “cold” tumor microenvironment (TME) lacking T cells that mediate
anti-tumor immunity and are necessary for immunotherapy responses, it was recently shown that a subset of
NEPC patient tumors are “inflamed” with T cells and have heightened expression of interferon gamma (IFNg)
signatures. As IFNg is associated with activation of adaptive immunity and better ICB outcomes, this suggests
that NEPC patients may potentially benefit from immunotherapy. To determine the impact of IFNg on tumor-
immune interactions in situ, I developed a novel mouse model of NEPC through in vivo electroporation of
CRISPR constructs targeting three tumor suppressor genes, Pten, p53, and Rb1 (PtPRb), commonly disrupted
in NEPC patients. Despite PtPRb NEPC tumors recapitulating the inflamed TME of human NEPC with enhanced
IFNg signaling and a significant influx of CD8+ T cells, paradoxically, mice failed to respond and even had worse
survival following anti-PD-1 ICB. Inhibiting Nuclear Factor kappa B (NFkB) signaling downstream of IFNg in
NEPC cell lines in vitro or blocking the IFNg receptor (IFNGR1) in NEPC tumors in vivo not only inhibited tumor
growth and prolonged survival, but also reduced the numbers of macrophages that highly infiltrate NEPC tumors
and can suppress T cell and immunotherapy responses. Based on these preliminary results, our central
hypothesis is that IFNg signaling contributes directly to tumor growth and macrophage dysfunction, and that
targeting it will activate immunotherapy responses in NEPC. In Aim 1, we will test whether IFNg signaling directly
contributes to NEPC viability and growth signaling. Genetic and pharmacological approaches will be used inhibit
different upstream and downstream IFNg signaling regulators in murine NEPC tumor cells and human NEPC
organoids to investigate their role in driving growth factor signaling and growth phenotypes in vitro and in vivo.
In Aim 2, we will test whether IFNg drives macrophage-mediated immune suppression and immunotherapy
resistance. The impact of IFNGR1 KO on macrophage polarization, phenotypes, and T cell interactions will be
assessed in vitro by tumor-immune co-culture assays and in vivo in murine NEPC tumor models by multiplexed
error-robust fluorescence in situ hybridization (MERFISH) spatial transcriptomics. Finally, we will evaluate the
effects of macrophage or IFNGR1 blockade on tumor and immune responses and anti-PD-1 ICB outcomes in
our preclinical NEPC animal models. Ultimately, this work will not only unveil new tumor intrinsic and extrinsic
mechanisms by which IFNg signaling drives NEPC progression, but also advance novel strategies targeting IFNg
regulators to enhance immunotherapy outcomes in this aggressive disease.

Public health relevance
PROJECT NARRATIVE We do not currently have effective treatment regimens for prostate patients that develop neuroendocrine prostate cancer (NEPC) following hormone therapy failure. This proposal aims to characterize the role of interferon gamma (IFNg) signaling that we find to be elevated in NEPC on tumor growth, immune suppression, and the outcomes of immune checkpoint blockade immunotherapy. Successful completion will lead to a better understanding of the signaling pathways the drive NEPC progression and the development of novel immunotherapy regimens to treat aggressive NEPC.